Mitochondrial Calcium and Neuronal Health

ABSTRACT
Propagation of calcium (Ca2+) signals to the mitochondria through the Ca2+ uniporter has long been considered
central to neuronal function. The discovery of the molecular components of the uniporter including the Ca2+
sensing regulator MICU1, was followed by the identification of many MICU1 loss-of-function patients who display
progressive neurological disorder, dominated by motor and learning impairments, which were recapitulated in
mouse models created by us and others. Emerging evidence indicates that acute MICU1 proteolytic degradation
by YME1L also occurs during hypoxia, suggesting that dysregulation of mitochondrial Ca2+ homeostasis may
also play a role in ischemia/stroke. However, the neuronal pathogenesis associated with MICU1 deficiency and,
more broadly, the role of uniporter regulation in healthy neurons, remain poorly understood. MICU1 forms dimers
with its paralogs, MICU2 and MICU3, and with itself. MICU2 has also been linked to human neurological
impairments but is scarce in adult neurons, whereas MICU3 is abundant in adult brain. Our central hypothesis
is that control of mitochondrial Ca2+ uptake by MICU1/2/3 is essential for coordinating mitochondrial function with
synaptic activity. This control also prevents mitochondrial Ca2+ overload and oxidant dysregulation that lead to
neuronal stress. Further, we postulate dynamic tuning of neuronal MICU-dependent gatekeeping: during
development—by a switch from primarily MICU1-MICU2 to MICU1-MICU3 dimers during early life—and under
hypoxic stress, by specific proteolytic degradation of MICU1, with potentially pathogenic consequences. To test
these ideas, we will use a neuron-specific MICU1 knockout mouse which we found to display neurodegeneration
characterized by mitochondrial Ca2+ overload, altered mitochondrial and neuronal ultrastructure, and motor and
cognitive impairments. We have also generated mice with MICU2 and MICU3 loss and have obtained MICU1
and MICU2 patient-derived cells. We have set up advanced functional imaging and large volume 3D
ultrastructure capacities. Thus, we are well positioned to study the neuronal pathogenesis associated with the
loss of each or multiple MICU isoforms. In Aim#1 we will test the hypothesis that neurons derived from MICU1,
MICU2 or MICU3-deficient mice and MICU1 and MICU2-deficient patient fibroblast-derived neurons have distinct
impairments in Ca2+ signaling, mitochondrial dynamics and synaptic vesicle release. In Aim#2 we will test if
neuronal MICU1/2/3 loss promotes mitochondrial oxidant production and oxidant-mediated cell injury. The
results will help to decide if oxidants are relevant to MICU-linked neuronal/brain injury. In Aim#3 we will test the
hypothesis that the relative abundance of the different MICU isoforms is dynamic in neurons during development,
and the loss of each isoform specifically affects neuroanatomy and brain function primarily in the motor areas
and the hippocampus. In Aim#4 we will test if ischemia-reperfusion induces YME1L-mediated turnover of MICU1
to promote mitochondrial Ca2+ overload injury and to sensitize the uniporter to inhibitors. These studies are
expected to decide if MICU1 loss is a pathogenic component and therapy-modifying factor in brain hypoxia.

Public health relevance
Narrative Impaired mitochondrial calcium homeostasis has been linked to both common and rare neurological disorders. Recent evidence indicates that genetic loss of the gatekeepers of mitochondrial calcium uptake, MICU1/2, causes progressive neurological disease in both human and mouse but the underlying mechanism remains elusive. The proposed work will help to understand the dynamic and complex physiological involvements of the MICU proteins, and the neurological pathogenesis caused by their inherited as well as acquired acute loss.